Pain mechanisms in the female reproductive tract

Project Summary/Abstract
Pelvic pain is a significant health burden affecting a large proportion of women worldwide. Up to 11% of
women are diagnosed with endometriosis, and 80% may develop fibroids, with 25-50% experiencing pain
symptoms. Additionally, many women experience chronic pelvic pain of unknown origin. These conditions
have a staggering economic impact, with annual healthcare costs exceeding $10 billion in the United States
alone, and profoundly affect quality of life, causing chronic pain, reduced productivity, and impaired social
functioning. Despite the high prevalence and substantial impact on quality of life, the sensory mechanisms
underlying female reproductive pain remain poorly understood, hindering the development of effective
therapies. In other visceral organs such as the intestine and lung, serotonin and ATP have been shown to
transmit nocifensive signals that initiate pain sensation. In the gut, serotonin-producing enterochromaffin
cells act as polymodal stress sensors, releasing serotonin and ATP to activate gut-innervating sensory
neurons and evoke nausea and pain. Similarly, in the lung, pulmonary neuroendocrine cells release ATP to
trigger protective respiratory reflexes. This proposal aims to elucidate the role of serotonergic and purinergic
signaling pathways in mediating nociception within the female reproductive tract. Our preliminary data show
that serotonin-producing cells and serotonin-sensitive nerve fibers are present in the female reproductive
tract. We hypothesize that these serotonergic and purinergic pathways serve as key components of
nocifensive sensory circuits, analogous to their roles in other visceral organs. To test this hypothesis, we will
employ state-of-the-art techniques, including genetically encoded neurotransmitter sensors and optogenetic
tools, to characterize the molecular and functional properties of these signaling pathways. In Aim 1, we will
identify the source of serotonin and characterize the stimuli that trigger its release. Aim 2 will investigate the
functional connectivity between serotonin-producing cells and sensory neurons, and assess the behavioral
consequences of activating this pathway, including pain responses. Aim 3 will focus on identifying the cellular
origin of ATP and its role in nocifensive signaling. By delineating these novel sensory circuits, we aim to
bridge the critical gap in understanding pelvic pain and create new intellectual space for developing targeted
therapies in Women's Health. This research has the potential to transform our understanding of female
reproductive pain and guide the development of novel, mechanism-based interventions for endometriosis,
fibroids, and other debilitating conditions affecting millions of women worldwide.

Public health relevance
Project Narrative This research proposal investigates the role of the neurotransmitters serotonin and ATP in transmitting pain signals within the female reproductive system, aiming to uncover the underlying mechanisms of pelvic pain that affect millions of women worldwide. By identifying the specific cells and pathways responsible for transmitting pain signals, this project will lay the groundwork for future development of targeted treatments for female reproductive pain. These findings aim to alleviate suffering and improve the quality of life for those affected by conditions such as endometriosis, fibroids, and chronic pelvic pain, ultimately reducing the substantial healthcare costs and societal burden associated with female reproductive pain.